Defining the Connectivity and Dynamics of Peripheral Sour Taste Circuits

Abstract
The sense of taste is a complex and integrative chemosensory system that guides consummatory behavior. Taste
receptor cells (TRCs) in the taste bud are continuously renewed and must reconnect with peripheral gustatory
neurons (GNs) to relay taste signals to the brain. The turnover and re-establishment of peripheral taste synapses
is vital to maintain this complex sensory system. Studies have demonstrated the molecular mechanisms
governing the differentiation, maturation and turnover of TRCs as well as the identification of molecularly and
functionally separate populations of geniculate ganglion neurons. However, the synaptic connectivity and
dynamics between TRCs and GNs remains unknown due to the lack of technologies to examine them. To
overcome this, I have developed GFP Reconstitution Across Synaptic Partners (GRASP) to visualize synaptic
contacts in the taste bud. GRASP consists of pre- and post-GRASP split GFP molecules expressed, directed, and
anchored into the synaptic membranes of pre- and post-synaptic cells, respectively. Because expression of the
GRASP components can be controlled genetically, we can use it to assess the connectivity of specific populations.
Moreover, GRASP produces bright fluorescent signals in native tissues which grants the unique ability to study
synapse dynamics in time-lapse studies. In preliminary work, I have created transgenic mice that express the
cyan variant of the pre-GRASP protein under the PKD2L1 promoter, a marker for sour TRCs. Additionally, I have
engineered Flex-switch post-GRASP AAVs which enables us to express the post-synaptic GRASP in GNs. With
this novel technique at hand, my goal is to genetically identify potential GN-TRC synaptic partners and to
characterize synaptic dynamics during taste cell turnover, using sour TRCs as a model. To achieve these goals,
this proposal will investigate two aims, 1) Identify synaptic partners for sour TRCs in the fungiform,
circumvallate, and laryngeal taste buds, and 2) Determine the longevity and dynamics of sour TRC synapses over
time. This proposal is designed to use GRASP, a novel and innovative technique, to elucidate synaptic
connectivity and dynamics in the peripheral taste system, which will have far-reaching impact in the fields of
taste development, connectivity, and taste disorders.

Public health relevance
Narrative The sense of taste allows us to identify nutrients and avoid toxins within food, which is essential to maintain health and homeostasis. Taste dysfunction can lead to malnutrition and a decreased quality of life, but identifying the underlying causes and potential treatments for taste dysfunction is hindered by a limited understanding of how taste receptor cells and peripheral gustatory neurons re-establish connections in the taste bud during taste receptor cell turnover. This proposal seeks to define synaptic partnerships and dynamics during the continual turnover of taste receptor cells.